Role of BK gamma subunits in renal K secretion

ABSTRACT: Maintenance of whole-body K+ homeostasis is a vital biological function carried out primarily by the
aldosterone sensitive distal nephron. Detailed understanding of the physiology underlying this process is critical
to the management of patients with dysregulated K+ balance, an outcome arising from a number of different
pathological conditions. In general, the kidney must eliminate a surplus of dietary K+ to maintain circulating levels
between 3.5 and 5 mM. This is achieved, in part, by the activity of large conductance, Ca2+-activated K+ (BK)
channels expressed on the apical membranes of intercalated cells (ICs). Under conditions of high tubular flow
rates, such as with volume expansion or excess K+ intake, BK channels open to allow bulk transport of K+ into
the tubule lumen in a process termed “flow induced K+ secretion.” BK activation in this context is unusual because
these channels are typically only activated by significant membrane depolarization and/or intracellular Ca2+
elevations. Given that ICs are not electrically excitable, and that sustained intracellular Ca2+ elevations are
usually cytotoxic, we propose that another mechanism allowing for BK activation is likely to be involved in flow
induced K+ secretion. This project is focused on investigating the role of a newly described class of auxiliary γ
subunits in regulating BK-mediated K+ secretion in the distal nephron. This subunit family (BKγ1-4), encoded by
members of the leucine rich repeat containing protein family (lrrc26, 52, 55, and 38, respectively), has received
recent attention for their ability to shift the channel’s activation threshold to near resting membrane potential,
even at low Ca2+ levels. This allows for sustained BK activity without the need for extensive depolarizing or
calcinergic stimuli. BKγ subunits have been described as having profound effects on channel function in a variety
of cell types throughout the body and, in particular, by epithelial cells that carry out vectorial K+ transport. We
provide novel evidence that one of these auxiliary subunits (BKγ2; lrrc52) is highly expressed in ICs and is
upregulated by dietary K+ loading, which is associated with flow induced K+ secretion. We propose to investigate
how BKγ2 is regulated by K+ intake and define its functional role in distal nephron K+ handling. In Aim 1, we will
quantify changes in BKγ2 expression in response to various dietary K+ challenges, delineating the cell-specific
expression pattern and exploring the potential influence of sex as a variable. We will further identify the role of
aldosterone signaling in regulating BK subunit expression in ICs by using an IC-specific knockout of the
mineralocorticoid receptor. In Aim 2, we will combine patch clamp electrophysiology, isolated tubular perfusion,
and metabolic cage approaches to assess BK channel function, and K+ handling in general, in WT versus
BKγ2-/- mice. These studies will allow us to define, for the first time, the role of these subunits in renal K+ transport,
as well as to explore the physiological mechanisms that regulate their expression in a cell-specific manner. Our
findings will significantly advance the current understanding not only of renal K+ handling, but also of the broader
importance of BKγ subunits as a novel class of BK channel regulatory proteins.

Public health relevance
PROJECT NARRATIVE: This proposal is focused on investigating a novel component of K+ handling by the kidney, which has important implications for maintaining appropriate electrolyte balance in healthy and diseased states. The mechanisms to be studied in this project, which involve the regulation of specific K+ channels, have not yet been explored in the context of renal K+ transport. Over the course of these studies, we will generate important new insights into kidney physiology that carry a high degree of clinical value.